Role of RIPK2 in the neuroinflammatory response to ischemic stroke

Abstract
Neuroinflammation after stroke significantly contributes to neuronal damage and neurological impairment.
Delayed cell death in the ischemic penumbra is associated with glial activation and recruitment and infiltration of
peripheral immune cells to the brain. This is triggered by the production of pro-inflammatory cytokines and
chemokines, contributing to cell death and blood-brain barrier (BBB) permeability after stroke. Dying cells in the
penumbra also release pro-inflammatory signals and damage-associated molecular patterns (DAMPs) that
activate resident microglia toward a pro-inflammatory phenotype, thus further contributing to brain injury. Our
overall goal is to reduce the spread of stroke damage by limiting neuroinflammation.
Receptor interacting serine/threonine protein kinase 2 (RIPK2) is a critical mediator of inflammation via its
activation of multiple pro-inflammatory and cell death pathways. Inhibition of RIPK2’s kinase activity abolishes
its signaling to alleviate inflammatory conditions in the periphery. The role of RIPK2 in ischemic stroke remains
unexplored; however, our pilot data shows a substantial reduction in infarct size and improvement in post-stroke
functional outcomes, both acutely and long-term, in Ripk2 knockout (Ripk2-/-) mice compared to wild-type
(Ripk2+/+) mice. We propose that RIPK2 is an essential initiator and propagator of pro-inflammatory pathways in
ischemic stroke. Our main objective is to attenuate its activity and assess the specific role of RIPK2 in vivo as it
relates to stroke pathology. We hypothesize that RIPK2 signaling is detrimental in ischemic stroke, and RIPK2
degradation/inhibition or selective ablation in myeloid cells will improve outcomes.
Aim 1 will determine the neuroprotective effect of RIPK2 blockade after ischemia using a highly selective
RIPK2 inhibitor and a proteolysis-targeting chimera (PROTAC) that specifically degrades RIPK2 in vivo. We will
utilize aged mice of both sexes subjected to ischemic stroke and investigate the effects of RIPK2 blockade on
infarct size and long-term behavioral outcomes. In Aim 2, we will determine the impact of RIPK2 blockade on
stroke-induced neuroinflammation and investigate neuroprotection mechanisms. In Aim 3, we will dissect the
cell-specific role of RIPK2 in the neuroinflammatory process after stroke by using Ripk2 floxed mice crossed with
lines producing Cre recombinase in specific cell types. We will study the contribution of RIPK2 from myeloid-
lineage cells and brain-resident microglia to stroke injury. This project will leverage our expertise and unique
tools (Ripk2 floxed mice, PROTAC, and selective inhibitors) to understand the mechanisms of RIPK2-driven
inflammation in the context of ischemic stroke. This research may lead to identifying RIPK2 as a new therapeutic
target to block neuroinflammation and promote neuronal survival in the aftermath of an ischemic stroke.

Public health relevance
PROJECT NARRATIVE The overall goal of this R01 application is to understand the role of RIPK2, a key initiator and propagator of inflammatory signaling, in clinically relevant animal models of ischemic stroke. The proposed research is relevant to public health because it will help understand the potential therapeutic value of RIPK2 inhibitors to reduce brain damage and improve neurological recovery following stroke. This proposal is relevant to the NINDS's mission that pertains to developing significant knowledge in basic research that will create the foundation for treating ischemic stroke and reducing the burden of this neurological disease.